STATISTICS

Core B is the Data Management/Statistical component ofthe Center. Core B provides central support for all data-related activities for the other cores and the four projects. Responsibilities of the staff of Core B include data form creation, database construction, data management, participant tracking, data security, logic checks, coordination of data acquisition, and statistical and analytic support. The direct involvement ofthe Core B staff in all data-related activities will provide consistent and accurate data and statistical analyses for the investigation into associations with CVD risk in this population. The Core B staff will also work with program investigators to develop statistical models to test associations in the intervention populations.

Public health relevance
Activities ofthe Core B v¿ll provide accurate and high-quality data and analytic support to address the questions ofthe Center and to make explicit the relationship between psychosocial stress, genetics, local environmental factors and allostatic load v¿th these selected chronic conditions among Puerto Ricans living around Boston, MA.